Parkinson's Disease Neuroprotection Clinical Trial

DESCRIPTION (provided by applicant): Description not provided by applicant.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relevance statement not provided by applicant.